Resources and Workforce Development for Research on NIH/NIAID High Priority Pathogens at the University of Missouri Regional Biocontainment Laboratory

Overall Project Summary
Resources and Workforce Development for Research on NIH/NIAID High Priority Pathogens at the University
of Missouri Regional Biocontainment Laboratory
The University of Missouri Regional Biocontainment Laboratory (RBL) was commissioned in 2009 as an $18M,
12,377 NSF BSL-3/ABSL-3 facility. During its thirteen years of operation, the RBL, since named the MU
Laboratory for Infectious Disease Research (LIDR) has been a centerpiece of the broader infectious disease
research community at the University of Missouri, receiving strong institutional commitment in the recruitment
and sustainment of world-class faculty for management of the RBL/LIDR and for conducting research on high
priority pathogens. The LIDR operates shared research resources, including state-of-the-art equipment and
professional services in microbiology, aerobiology, immunology, and animal model core facilities that serve the
needs of researchers on campus and in the broader regional and national communities. The faculty and
professional staff of the LIDR are part of the NIH/NIAID RBL-NBL network, with collaborative interactions that
facilitate sharing of best practices and knowledge, providing synergy in achieving our collective biodefense and
emerging infectious disease research agenda. During the COVID pandemic, the MU LIDR, along with its RBL
and NBL partners, led the response to the pandemic and are committed to strengthening pandemic
preparedness of the nation, by providing BSL-3/ABSL-3 training, professional staff, and research services that
allow for rapid responses in all areas, including development of animal models and the evaluation of numerous
treatments, disinfectants, and vaccine platforms to combat the pandemic. The long-term goal of the present
application is to sustain a leading effort for development of novel medical countermeasures for combating the
ever present and changing threats of emerging and re-emerging infectious diseases, while training an
outstanding cadre of next generation scientists and professionals in biocontainment. The goals of the proposed
cores in Facility Management, Maintenance and Operations, BSL3 Practices, and Biocontainment Research
Support Services are to educate and train the next generation of scientists and biocontainment professionals in
biodefense and emerging infectious diseases, and to facilitate and enhance the development of novel
approaches for prevention and treatment of infections caused by high consequence pathogens whose natural
or deliberate transmission pose a threat to public health and national security. Towards these goals, the proposed
Cores will work within the broader infectious disease community at MU and the NIH/NIAID RBL-NBL network for
enhancement of research productivity and discovery, and continued sharing of information and best practices in
order to meet the changing priorities and needs of NIH/NIAID for biodefense and emerging infectious diseases.

Public health relevance
Project Narrative/ Public Health Relevance Emerging and re-emerging infectious diseases present unique challenges in the research mission of the NIH/NIAID because pathogen evolution cannot be predicted, and development of medical countermeasures that protect public health is reliant upon well characterized animal models that recapitulate the natural human infection. As these studies demand specialized personnel and building infrastructure, the NIH/NIAID Regional Biocontainment Laboratories were constructed to better address these challenges and prepare for unexpected outbreaks by unknown microbial threats. The proposed program will provide safety, security, and operational support to researchers at the University of Missouri Regional Biocontainment Laboratory in order to address priority pathogens and develop new approaches to prevent and treat infections, thereby improving our preparation for responding to an outbreak of emerging infectious disease.